MOMI Administrative Core

Administrative Core: Summary
Pregnancy represents a unique immunological state that has been largely overlooked for decades in the
field of immunology. This HIPC program aims to support the deep immunological characterization and
investigation of immunity during pregnancy to inspire next generation vaccine development to protect this unique
segment of the global population that are more vulnerable to infection. The Administrative Core (AC) will play
a critical central role in shaping the success of the overall program offering administrative, structural, and clinical
support to the program, nucleating all efforts as well as performing the necessary outreach to collaborators,
funders, and public/private partners. The AC will create digital and live platforms for the free exchange of
scientific information, will serve to facilitate access to samples and data, will support the acquisition of samples
for the program, will support legal agreements for sample and data sharing, will support training/mentorship, and
will function in financial and programmatic management to ensure the success of the overall program. In addition,
the AC will coordinate participation in program evaluation activities, including progress reports, site visits, and
provide additional communication and materials to the NIH as needed. Finally, the AC will also function to
maintain interactive practices that maintain cohesion across the team as well as the entire HIPC, ensuring that
all investigators are engaged in the overall success of the program and ultimately into translating findings for the
development of truly innovative products to reshape vaccine development for pregnancy and other
immunosuppressed populations.